Neurobiological mechanisms underlying chronic tolerance to the aversive properties of ethanol

PROJECT SUMMARY
Chronic alcohol exposure is associated with the development of tolerance to alcohol’s aversive properties, which
serve to limit drinking. The brain undergoes a host of neuroadaptive changes as a result of chronic alcohol
exposure but the neural mechanisms underlying this tolerance are unknown. Impaired signaling in circuits
encoding aversion is a likely candidate mechanism. The rostromedial tegmental nucleus (RMTg) is characterized
for its involvement in aversion including signaling the aversive properties of ethanol. The aims of the parent grant
are designed to test the hypothesis that dependence-induced plasticity in RMTg-projecting neurons in discrete
subregions of the medial prefrontal cortex (mPFC) facilitates chronic tolerance to ethanol’s aversive properties.
This hypothesis is supported by the presence of dense connectivity and significant functional overlap between
the mPFC and RMTg. However, the RMTg also receives input from the anterior insular cortex (AIC). The AIC is
critically involved in processing interoceptive information to guide behavioral responding to environmental stimuli
including those associated with reward and aversion. In particular, loss of AIC function results in behavioral
deficits in response to aversive stimuli. While the function of this neural circuit is not yet known, data from our
lab suggests that both the AIC and RMTg play a role in signaling information regarding the aversive properties
of ethanol. Like the mPFC, significant neuroadaptive changes are also observed in the AIC following chronic
ethanol exposure. The current proposal is designed to investigate whether dependence-induced alterations in
AIC-RMTg circuitry are also mechanistically involved in tolerance to ethanol’s aversive properties via a set of
experiments that parallel those proposed in the parent grant. Aim 1 will use in vivo fiber photometry to measure
changes in calcium signal in RMTg-projecting AIC inputs during the development of tolerance. Aim 2 will use
whole-cell patch-clamp slice electrophysiology to identify dependence-induced changes in glutamatergic
signaling underlying tolerance to ethanol’s aversive properties. Additional studies will use a virally-mediated
intersectional approach to determine whether changes at the physiological level that occur after tolerance are
also associated with changes in dendritic spine density and morphology. The results of these studies will
augment the findings generated in the parent grant and shed new light on the possible synergistic role played
by the AIC and mPFC in the mechanisms underlying chronic tolerance to the aversive properties of ethanol. In
addition, this award provides an opportunity for the minority candidate to gain new training in cutting-edge
approaches in addiction neuroscience in a rich scientific environment under the mentorship of a highly successful
NIAAA-funded PI within the Center for Alcohol Research in Epigenetics. Findings generated with the support of
this award will serve as a foundation for the candidate to develop a National Research Service Award application
to further her training and career development as an alcohol researcher.

Public health relevance
PROJECT NARRATIVE Chronic alcohol exposure produces tolerance to alcohol’s aversive properties, which functions to release the brake on drinking, contributing to difficulty controlling consumption. The neurobiological mechanisms underlying this effect are not well understood but likely include alterations in neural circuits involved in aversive signaling. The project proposed in the current application will examine the role of inputs from the anterior insular cortex to the rostromedial tegmental nucleus in driving chronic tolerance to alcohol’s aversive properties.